Alzheimer Mouse Model for Intraneuronal Amyloid-Beta Oligomer Biology

Project summary Recently, much attention has turned to the study of so-called oligomeric forms of the amyloid beta peptide (Aβ)) as possible key mediators of dementia in Alzheimer's disease. We have chosen to exploit the propensity of Dutch Aβ to form oligomers is order to create a transgenic mouse model of the biochemical pathology, neuropathology, and behavioral pathology of neuronally-derived Aβ oligomers by overexpressing Dutch APP on the Thy1 promoter (Thy1-Dutch APPE693Q transgenic mouse line). In preliminary characterization of these Thy1-Dutch APPE693Q mice, we have observed aging-dependent cognitive decline and a number of quantifiable neuropathological changes. However, in our hands, Thy1-APPE693Q mice never develop parenchymal amyloid deposits of any sort during their lifespan; however, immunodetectable Aβ oligomers accumulate, and these oligomers appear to be localized to the neuronal endosomal-lysosomal system. In order to generate Aβ histopathology, we have crossed the Thy1- Dutch APPE693Q mice with familial Alzheimer's mutant presenilin lacking exon 9 (PS1Δ9). This pathogenic mutant form of PS1 elevates levels of Aβ42, thereby causing plaques to form in bigenic mice (these mice are designated Thy1-Dutch APPE693Q x PS1Δ9 bigenics). However, while the mutant PS1 causes plaques to form, the appearance of amyloid plaques has no obvious effect on the time course or initial severity of cognitive decline. In summary, we observe: (1) accumulation of intraneuronal APP/Aβ derivatives in single Dutch APP transgenic and bigenic PS/APP mice; and (2) accumulation of Dutch CAA. For this MERIT application, we propose to perform quantitative characterization of single Dutch APP transgenic and bigenic PS/APP mice, according to gender and at various ages over their lifespans, using (a) Assessment of behavioral performance in the Morris water maze and inhibitory avoidance models of spatial learning and memory; (b) Quantification of brain levels of APP, α and β CTFs, Aβ40, Aβ42, Aβ oligomers, and synaptophysin; (c) Subcellular localization of APP-Aβ-like immunoreactivity, including Dutch CAA; (d) Quantitative morphometry to determine integrity of hippocampal neuronal populations and to estimate intraneuronal Aβ burden. The availability of lines of mice that are impaired by oligomers and never develop amyloid plaques would greatly facilitate the construction of in vivo efficacy screens in the search for anti- oligomer drugs for the treatment of Alzheimer's disease.

Public health relevance
PROJECT NARRATIVE Most living veterans of World War II (estimated to be over 10 million in 1983) are now over 85 years old, and half of those veterans are probably suffering from Alzheimer's disease. Veterans of Operation Iraqi Freedom/Operation Enduring Freedom have a high incidence and prevalence of post traumatic brain injury (TBI) dementia (Lew et al., 2008). Advances in genetics have enabled the discovery of Alzheimer's genes and the creation of mouse models of Alzheimer's pathology. Genes point the way to protein variants, called oligomers (Klyubin et al., 2008; Shankar et al., 2008), and we are seeking to test whether levels of oligomers correlate with severity of behavioral pathology. If confirmed, then these mouse models that form oligomers will be important for the development of anti-oligomer drugs that could be useful in treating, delaying, or preventing the dementia associated with Alzheimer's and/or post-TBI dementia.